Project 2: KSHV induces tumorigenesis by harnessing differentiation in hypoxia

Summary
Hypoxia is a characteristic feature of solid tumors and an adverse prognostic factor owing to its contributions to
tumor progression and resistance to therapy. Kaposi's sarcoma (KS) preferentially develops in the lower
extremities of the body, where blood vessels are often poorly oxygenated, suggesting that hypoxia also plays
roles in KS development. Indeed, KSHV infection of endothelial cells or mesenchymal stem cells (MSCs)
activates hypoxia-induced factor (HIF), a master regulator of both developmental and pathological
angiogenesis. In turn, hypoxia and HIFs affect KSHV biology and KS development. However, given the highly
vascular phenotype of KS tumor, we wonder that the hypoxia response may not be the consequence of
hypoxia condition, but a strategy that KSHV adapts to promote MSC differentiation towards KS phenotypes.
KS lesions are characterized by proliferating KSHV-infected spindle cells, intensive angiogenesis and
infiltrating inflammatory cells. The origin of KS spindle cells remains contentious. Recently we found a series of
evidence suggesting that KS derives from oral mesenchymal stem cells (MSCs) through a mesenchymal-to-
endothelial transition (MEndT) process (Li et al., 2018). These findings revealed novel viral tumorigenesis that
cancer can arise from pluripotential stem cells when an oncogenic virus hijacks their differentiation process.
Inspired by the exciting discovery, we attempt to elucidate the mechanism underlying KSHV-driven MEndT and
tumorigenesis. Our preliminary study showed that the transcriptomes of KSHV infected MSCs and KS lesions
largely overlap with that of hypoxia cultured MSCs, raising a possibility that KSHV infection harnesses hypoxia
response to promote MSC differentiation leading to KS. We will investigate this hypothesis with three specific
aims as follows. (i) We will determine how KSHV promotes MSC differentiation through the hijacking hypoxia
response system. (ii) We will identify signaling pathways altered by KSHV and hypoxia and investigate their
contribution to MEndT, angiogenesis and inflammation, therefore elucidating the mechanism underlying KSHV
and hypoxia-mediated MEndT. (iii) We will characterize epigenetic regulation in MSCs during MEndT, and
reveal how KSHV alters the regulation leading to KS. Through these studies, we will ultimately address the
question of how KSHV transforms MSC to KS tumor.
Our proposed studies are highly innovative and of biological significance. First, the study will prove a
paradigm-shifting concept on the nature and cellular origin of Kaposi's sarcoma that KS spindle cells derive
from KSHV-infected mesenchymal stem cells. Second, the study will reveal a novel mechanism underlying the
emergence of KS tumor cells through KSHV-driven MEndT and new insights into the multifocal and oligoclonal
nature of KS. Third, this study will elucidate how KSHV harnesses hypoxia response to promote MSC
transformation to KS and validate hypoxia as an effective therapeutic target for the treatment of KS.

Public health relevance
Narrative Evidence from our recent study suggests that Kaposi’s sarcoma (KS) originates from oral mesenchymal stem cells (MSCs) through KSHV-induced mesenchymal-to-endothelial transition (MEndT). In this proposal, we will investigate the hypothesis that KSHV hijacks the cellular intrinsic hypoxia response to drive MSC to special lineage differentiation and commit oncogenesis. This study will provide mechanistic insights into how KSHV promotes MSC MEndT and oncogenic properties leading to KS.